HYPOXIC SENSITIZER SR-2508 AND RADIATION IN HEAD AND NECK CARCINOMA

Phase II study of the effectiveness of the hypoxic cell sensitizer SR-2508 in combination with radiotherapy in locally advanced head and neck carcinoma.